Relationship of the Human Astrocyte Matrisome with Synaptic Networks

PROJECT SUMMARY-ABSTRACT
Astrocytes are highly-abundant cells in the nervous system and they play a critical role in the
orchestration of neuronal synaptic networks. One of the primary mechanisms through which they influence
neuronal synapses is thought to involve signaling via a diverse milieu of extracellular proteins (i.e., the astrocyte
matrisome). However, it remains unclear which components of the astrocyte matrisome are necessary and
sufficient for the formation and strengthening of neuronal excitatory synapses, especially in human-specific cells
due to current limitations in experimentally investigating human neural networks using traditional monolayer
cultures and immature organoids. To overcome these technical limitations, we will utilize our recently optimized
approach which generates and analyzes bioengineered neural organoids that are composed of specific numbers
of post-mitotic astrocytes as well as neurons that are directly transdifferentiated from human pluripotent stem
cells. Specifically, we will use these bioengineered neural organoids to test the hypothesis that mature human
astrocytes produce a cell type-restricted, multi-component, activity-dependent matrisome that accelerates the
formation and function of neuronal synaptic networks. Our preliminary data confirms feasibility of our organoid-
based approach to test this hypothesis and has identified top candidate proteins potentially underlying the
astrocyte-to-neuron influence on synapses. In Aim 1, we will determine whether human astrocyte
Thrombospondin 1 protein is a sufficient and necessary inducer of human neuronal synapses. We will use a
combination of genetic engineering and drug treatment to conclude whether Thrombospondin 1 promotes
structural and function excitatory synaptic networks and if it acts through signaling to the neuronal alpha2delta-
1 receptor. In Aim 2, we will define the extracellular human astrocyte matrisome and test its influence upon
neuronal synapse formation using a novel indirect coculture approach. Cocultures will be enabled by cellular
encapsulation within alginate hydrogel capsules to elucidate the extracellular astrocyte matrisome components,
test their effect upon neuronal organoids, and identify relevant receptor-ligand pairs. We will investigate whether
astrocyte-derived extracellular Thrombospondin 1 and/or chondroitin sulfate proteoglycans influences synapse
formation and function. Finally, in Aim 3, we will test how neuronal activity influences the synapse-promoting
characteristics of the human astrocyte matrisome. Neurons will be activated and paced using optogenetic tools,
and the resultant effect on cocultured astrocytes will be determined using a combination of single cell
RNAsequencing, pharmacological treatment, protein assays, and calcium imaging. The completion of our aims
will deliver novel experimental cell lines and protocols to the scientific community, and may identify novel
approaches to accelerate neuronal synaptic network formation in organoid-based model systems. Broadly, we
expect our studies to make significant contributions to the neurobiology field by identifying and defining
intercellular signaling mechanisms between human astrocytes and neuronal synapses.

Public health relevance
PROJECT NARRATIVE Healthy brain activity depends on intercellular signaling between neuronal synapses and extracellular proteins produced from astrocytes. We aim to understand the specific mechanisms underlying this astrocyte-neuron relationship in human cells using bioengineered neural organoids as an experimental testing platform. The results from this study are expected to elucidate the influence of astrocyte-neuron interactions, to deliver validated innovations that will improve organoid-based technologies, and to identify proteins with high potential as therapeutic targets during states of dysregulated brain activity.